Developing shared medical appointments for informal caregivers of Alzheimer’s and Dementia patients to improve knowledge, communication, and advanced planning

Project Summary
The prevalence of Alzheimer's Disease and related Dementias (ADRD) is expected to triple by 2060, affecting
about 14 million Americans. As ADRD progresses, symptoms worsen, putting informal caregivers (ICs) in charge
of tending to patients' needs. The majority of ICs are unprepared for the challenges of ADRD and are unaware
that the condition is fatal. Although advance care planning (ACP) discussions about goals and care are
encouraged, studies have revealed that they do not promote end-of-life (EOL) conversations. Clinicians do not
have enough time for in-depth discussions and when they do occur, they are one-time events during the initial
diagnosis when ICs are distressed and overwhelmed. We propose developing shared medical appointments
(SMAs), which are billable, group appointments in which participants are encouraged to ask questions and share
their concerns and experiences. SMAs are an ideal environment for EOL discussions because barriers such as
different cultural perspectives, health literacy, and time constraints are all addressed. The long-term goal of the
proposed study is to conduct a randomized control trial of SMAs across several hospitals to determine if they
facilitate increased knowledge about ADRD and promote goal-concordant about EOL issues. The objective of
this proposal is to identify the most significant EOL concerns in order to create a SMA that includes culturally
sensitive appropriate content and is mindful of various health literacy levels. We will conduct surveys and
interviews to identify topics, then consult ADRD and caregiving experts about the structure of the SMA, and
evaluate the SMA using pre/post measures. The rationale of this proposal is that by allocating time and space
to discuss ADRD's progression toward EOL in an environment where knowledge, concerns, and experiences
can be exchanged, effective advance care planning will occur. PI Alpert is an expert in health communication
and qualitative research methods. His mentorship team includes experts in quantitative research methods,
intervention development, and evaluation (Dr. Rothberg), health literacy and EOL decision-making (Dr. Paasche-
Orlow), and palliative care communication (Dr. Wittenberg). Our study is innovative because we will solicit
recommendations from multiple stakeholders about informational and communication needs about ADRD and
EOL, and then use those recommendations to construct a new method of care (SMA) for eliciting EOL
preferences. The proposed study is significant because, while discussions about EOL care are encouraged,
current ACP practices fail to achieve goal-concordant treatment. SMAs enhance learning and support, increase
trust, and are widely accepted by physicians. This project is expected to have a positive impact by providing
evidence for the development of additional ADRD SMAs to increase understanding, improve family and patient-
clinician communication, inform attitudes toward palliative care and hospice, and overall, encourage thoughtful
discussions about approaching EOL.

Public health relevance
Project Narrative This project aims to develop a novel method to facilitate discussions about end-of-life options among patients with Alzheimer's Disease and related Dementias (ADRD), their informal caregiver, and clinicians. We will first conduct interviews and administer surveys to identify the most important topics related to ADRD's progression, the ideal timing for discussions, and how other factors such as health literacy, race, ethnicity, religion, and education can influence such discussions. Since end-of-life conversations related to ADRD are challenging and advance care planning discussions are usually a solitary event, we will design and evaluate a shared medical appointment (SMA), which offers a sense of community where physicians have the liberty to continuously discuss sensitive topics with a group of patients and their informal caregivers to increase knowledge, awareness, and preparedness of end-of-life approaches.